A Novel Targeted Therapy for Subarachnoid Hemorrhage

Summary
The goal of this project is to develop a therapeutic capable of treating subarachnoid hemorrhage
(SAH), a severe form of stroke characterized by bleeding into the subarachnoid space. Around
30,000 cases of spontaneous SAH occur in the US population every year. They are typically
caused by a ruptured cerebral aneurysm, whose risk factors include, high blood pressure,
smoking, family history and alcoholism. Aneurysmal SAH is associated with high mortality: 50%
of patients die within 30 days, and of the survivors many retain neurological deficits. We have
recently shown that the lipoxygenase ALOX15 is increased in macrophages adjacent to the
subarachnoid blood in a mouse model of SAH, contributing to early brain injury. SAH induced
brain edema was ALOX15 dependent and ALOX15 gene knockout reduced neuronal cell death
and improved behavioral outcome. Loxagen’s lead compound, BPN-27332, selectively inhibits
ALOX15 with high potency (IC50 = 80 nM) and can reduce neuronal cell death and improve
neurological outcome after SAH. In this project, we will pursue the following aims: Aim 1:
Synthesize sufficient amounts of BPN-27332 to support in vivo studies. Aim 2: Determine the
most effective dose, confirm target engagement by lowering ALOX15 product and determine the
optimal time window for treatment. These results will allow us to apply for a Phase II SBIR
where we will expand our investigations and develop BPN-27332 as novel therapeutic to treat
the brain injury resulting from subarachnoid hemorrhage.

Public health relevance
Project Narrative/ Public Health Relevance Statement Subarachnoid hemorrhage (SAH), a severe form of stroke associated with high mortality, currently has very limited treatment options. We have recently shown that the lipoxygenase enzyme ALOX15 plays a major role in mediating early brain injury after SAH. In this project we are aiming to develop a novel inhibitor of ALOX15 that we have identified as therapeutic to treat SAH.